Targeting Radiation-Induced Glioblastoma Invasion

PROJECT SUMMARY
Recurrent Glioblastoma (rGBM) displays aggressive tumor invasion throughout the brain and spinal cord. The
aggressive invasive behavior of rGBM emerges following initial fractionated radiotherapy, which induces
mesenchymal transition and subsequent extracellular matrix (ECM) remodeling. However, the role of this ECM
remodeling in establishing the immunosuppressive tumor microenvironment of invasive rGBM remains unclear.
We found that Collagen type I and III (COL I & III) showed minimal expression in the normal brain, whereas it
was highly upregulated in rGBM. Through genetic knockout and pharmacological inhibition, we demonstrated
that COL I & III play crucial roles in establishing the immunosuppressive tumor microenvironment (TME).
Mechanistically, COL-activated PI3K signaling enhances TGFβ1 expression, subsequently promoting the
induction of regulatory T cells and exhausted T cells in the TME. Based on our findings, we developed two
therapeutic approaches targeting invasive rGBM. First, we used blood-brain barrier (BBB)-permeable PI3K
inhibitors to suppress COL-mediated signals. We confirmed that a PI3K inhibitor improved the
immunosuppressive TME and extended survival in mouse models of invasive rGBM. Second, we engineered
CBD-IL-12, a fusion protein combining a collagen-binding domain with the immunostimulatory cytokine IL-12.
CBD-IL-12 demonstrated selective accumulation to tumor and enhanced therapeutic efficacy in rGBM mouse
model, particularly when combined with PI3K inhibitors. For clinical translation, we engineered a humanized
version of CBD-IL-12 and confirmed its safety in canines. Also, we analyze the therapeutic efficacy of human
CBD-IL-12 against human invasive rGBM model in humanized mouse reconstituted human immune
environment. The humanized CBD-IL-12 demonstrated remarkable therapeutic effects, resulting in a significant
reduction of both tumor burden and spinal dissemination. Based on these findings, we hypothesize that radiation-
induced COL-PI3K-TGFβ signaling contributes to the immunosuppression of invasive rGBM, and these cells can
be targeted using BBB-permeable COL signaling inhibitors and CBD- IL-12 immunotherapy. We will investigate
this through three specific aims: (1) Determine how COL-PI3K-TGFβ signaling induces immunosuppressive TME
in invasive rGBM using genetic knockout approaches and signal inhibitors; (2) Examine how CBD-IL-12
modulates the immunosuppressive TME by analyzing chemotactic factors and dendritic cells induction; and (3)
Evaluate the therapeutic synergy between CBD-IL-12 and BBB-permeable COL signaling inhibitors in clinically
relevant syngeneic rGBM mouse model and humanized rGBM mouse models. Upon successful completion of
these studies, we will gain crucial insights into immune evasion mechanisms of invasive rGBM and establish a
strong foundation for clinical translation. This novel therapeutic strategy could be broadly applicable to other
COL-expressing invasive malignancies, potentially transforming the treatment landscape.

Public health relevance
PROJECT NARRATIVE Recurrent glioblastoma is the most aggressive type of malignant brain tumor in adults, spreading extensively throughout the brain and spinal cord, with no effective treatments currently available. Our research goal is to understand how these invasive tumor cells change their surrounding environment to escape attack from immune cells, using sophisticated laboratory models that closely mirror actual patient conditions. These findings will lead to the development of new immunotherapy treatments that can effectively target these resistant brain tumors, offering hope to patients who currently have no effective treatment options.